Flow Cytometry

The Flow Cytometry Core (Flow) offers state-of-the-art instrumentation and consultation to
cancer researchers. It also provides investigators with the current and effective data analysis
software as well as secure data storage options. Basic and translational cancer research
projects being conducted by Holden Comprehensive Cancer Center (HCCC) members take
advantage of Flow's high-speed sorting, multi-parameter analysis, high efficiency purification of
cell subsets. New equipment includes two five-laser Cytek Aurora spectral analyzers with a 96-
well autosamplers that can perform up to 40 color analysis and cell sorting. Flow also offers
training and assists investigators with software programs available for interpretation and
analysis of data. Individual training of investigators and their laboratory personnel in use of the
bench-top instruments is provided which allows trained personnel access to these instruments
around the clock. Flow is in a constant process of developing new technology and services as
requested and/or needed by HCCC investigators.

Public health relevance
PROJECT NARRATIVE Not applicable